RNA:DNA hybrids and genome instability

DESCRIPTION (provided by applicant): Project Summary: Double stranded breaks (DSBs) in DNA can be misrepaired, causing gross chromosomal rearrangements (GCRs) such as translocations, large deletions, and chromosome loss. These GCRs are thought to be causative in speciation and human disorders, especially cancer. The causes of DSBs and associated GCRs in most human pathologies have eluded researchers. One potential source of these deleterious DSBs and GCRs may be hybrids that form between RNA and homologous chromosomal DNA sequences. My laboratory has provided important new insights into hybrid formation and hybrid-mediated GCRs using budding yeast as a model system. We developed important new tools: 1) a yeast artificial chromosome (YAC) as a powerful genetic and molecular reporter of hybrid-mediated GCR; 2) a simple cytological assay to detect hybrids in individual cells; and 3) a model locus in the YAC at which we can induce hybrid formation and hybrid-mediated GCRs. Using our model locus, we showed that aberrant RNAs were much more proficient at causing hybrid mediated GCR than canonical mRNAs. In addition, hybrids can form in trans; that is, at a locus distinct from the site of transcript synthesis. Remarkably, the formation of these hybrids is mediated by the RAD51 repair pathway. We propose to exploit these findings to define the parameters in RNA and DNA (sequence, length,etc) that both promote and repress hybrid formation, DSB formation and hybrid-mediated GCR. We also showed that hybrid and GCR formation are greatly elevated in many mutants defective in diverse aspects of RNA biogenesis. We propose to generate the first genomic maps of hybrids associated with GCR in wild type and mutants. These maps, along with the model locus studies, will provide critical insights into how cis and trans factors influene the interplay between transcription, GCRs and genome instability. We identified two anti-hybrid systems. The first utilizes RNase H, an enzyme that degrades RNA in hybrids, and the second uses Srs2, an antagonist of Rad51. These two anti-mutagenic systems have escaped study despite 50 years of intensive research on DNA repair. We propose to elucidate the molecular function and biological impact of these hybrid-removal systems through genetic, biochemical and genomic methods. Finally, the least understood component of hybrid-mediated GCRs is the conversion of hybrids to DSBs. We will use our model locus to develop methods to detect hybrid-mediated DSBs and elucidate their mechanism of formation. The feasibility of the proposed studies is extremely high because of our novel assays for hybrid and GCR analysis and existing powerful approaches available in budding yeast. There is a remarkable conservation between budding yeast and human cells in the processes of RNA and DNA metabolism. Emerging studies are beginning to reveal a similar conservation for hybrid-mediated GCRs. Given these precedents, the experiments in this proposal are likely to be applicable to higher organisms, with the potential to provide important insights into human health, such as cancer and birth defects.

Public health relevance
PUBLIC HEALTH RELEVANCE: Narative Chromosome rearrangements and loss, hallmarks of several human disorders including cancer, are caused by breaks in DNA . Recently scientists discovered that DNA can break when it forms an inappropriate hybrid with RNA, a normal product of DNA. Here, we investigate when and how RNA-DNA hybrids form in budding yeast to provide a foundation to assess their causative role in human pathology. __SpecificAimsTextDelimiter__ Specific Aims: Double stranded breaks in DNA (DSBs) can be misrepaired to cause gross chromosomal rearrangements (GCRs) such as translocations, large deletions, and chromosome loss. These GCRs are thought to be causative in speciation and human disorders including cancer. However, the causes of the DSBs responsible for GCRs have eluded researchers. Years ago, elegant studies showed that DSBs can arise when RNA hybridizes to chromosomal DNA. Recent studies from my laboratory and others have implicated these RNA:DNA hybrids as potent inducers of GCR and genome instability. To address fundamental questions about the molecular mechanism of hybrid and GCR formation, we developed three new tools for Saccharomyces cerevisiae: 1) a yeast artificial chromosome (YAC) that allows us to assess rapidly the role of gene products in hybrid formation and hybrid-mediated GCRs; 2) a cytological assay to detect hybrids in individual cells; and 3) a model locus on the YAC that allows us to define parameters of RNA and DNA important for hybrid formation and hybrid-mediated GCRs. Using our model locus, we showed that hybrids are much more likely to form from aberrant transcripts, and they can form in trans; that is, by an RNA annealing to a homologous locus distinct from its site of transcription. Remarkably, the formation of hybrids in trans is mediated by the RAD51 repair pathway that normally promotes invasion of single stranded DNA into double stranded DNA. We also identified 23 mutants defective in diverse aspects of RNA biogenesis (transcription initiation, elongation, export, and degradation) that increased hybrid levels at many loci in every cell. We propose that the access of RNA to DNA is limited by activities of RNA biogenesis factors (RNA binding, export, degradation), thereby preventing hybrid formation and GCRs. Finally, we identify two additional anti-hybrid systems, endogenous RNases H that degrade hybrids, and Srs2 that antagonizes Rad51. The numerous genes devoted to preventing/eliminating hybrids represent a large target, which when mutated, could cause the GCRs associated with human disorders. Here, we exploit these tools and concepts to elucidate how and when hybrids form, and how they lead to DSBs. These aims are extremely feasible because they are based upon methods that my laboratory and collaborators either have developed or have used extensively. Specific Aim 1. Define the determinants in RNA and DNA that modulate the formation of hybrids. 1A) Identify the RNAs at the model locus important for hybrid formation and genome instability. 1B) Define sequences in RNA and DNA that enhance or inhibit hybrid and GCR formation. The proposed studies will provide important insights into the parameters of RNA and DNA that modulate hybrid and GCR formation both in cis and in trans. These insights will provide a foundation to interpret results from our genome studies (see Aim 2) as well as in other model systems and human disease. Specific Aim 2. Determine how chromosomal proteins control the distribution of hybrids. 1A) Measure the level and location of hybrids genome-wide in wild type and mutants with elevated hybrids. 2A) Analyze RNA and DNA sequences found at RNA:DNA hybrid loci to identify and characterize common genomic features (sequence, genomic position, chromatin factors, etc). The proposed studies will provide the first genomic view of hybrid formation associated with GCRs in any organism. This knowledge, coupled with Aim 1, will elucidate how cis and trans factors modulate the interplay between transcription and genome instability. Specific Aim 3) Characterize three anti-hybrid systems. 3A) Determine genomic loci where the three anti-hybrid systems (RNases H, Srs2 - a Rad51 antagonist, and Sen1 - a RNA helicase) act to prevent hybrid formation. 3B) Identify partners of RNase H1 and H2 that control their activity in hybrid removal 3C) Determine the basis of Rad51-mediated hybrid formation in vitro as a foundation to understand how Srs2 inhibits this deleterious Rad51 activity. The prevention of hybrids by the RNases H and Srs2 systems represent major anti-mutagenic pathways that have escaped study despite 50 years of intensive research on DNA repair. This aim will help elucidate molecular function and biological impact of these hybrid-removal systems Specific Aim 4. Determine how hybrids cause DSBs. 4A) Develop assays to detect hybrid-mediated DSBs. 4B) Analyze the roles of DNA replication and cell cycle progression in hybrid-mediated DSBs. 4C) Perform an unbiased screen to identify factors that increase hybrid-mediated DSBs/GCRs. Our tools provide us with an unique opportunity to gain insight into the most understudied component of hybrid-mediated GCRs, the conversion of hybrids to DSBs.